TCC for Health Disparties: Informing & Influencing Health Policy and Practice

The proposed SHLI TCC will use the technicar core resources of the RCMI Center of Excellence for Clinical and Transiationai Research (R-CENTER) as well as the MSM G12/Multidisciplinary Biomedical Research Center (MBRC). These NIMHD funded programs are described under resources and environment, and components are included under collaborations and resources available to support sub projects and pilot projects, including biostatistical support, data management and bioinfonnatics support.